Cellular and circuit effects of genetic ablation of adult-born oligodendrocytes

PROJECT SUMMARY
Oligodendrocytes (OLs), glial cells in the central nervous system, critically contribute to neuronal conduction and
health. OLs wrap axons in insulating myelin sheaths – increasing conduction speed – and shuttle metabolites to
the local axon to provide necessary energetic support. OLs generate throughout life, deriving from a dedicated
pool of OL progenitor cells (OPCs) that tile the brain. Oligodendrogenesis, or the differentiation of OLs from
OPCs, is modulated in adulthood by neuronal activity; new OLs and myelin form at increased rates on circuits
activated by artificial stimulation or learning and memory tasks. This activity-dependent oligodendrogenesis is
consequential for circuit function; across a variety of paradigms, the irreversible genetic blockade of
oligodendrogenesis prior to learning results in significantly impaired behavioral performance. Furthering our
understanding of the roles adult-born OLs play on neuronal circuits will greatly expand our understanding of
neural-glial interactions and assist in determining the extent of functional benefits potentially garnered by
therapeutics that induce oligodendrogenesis. This study investigates the cellular biology and circuit interactions
of adult-born OLs, using a novel knock-in mouse line enabling the selective labeling and delayed ablation of new
OLs generated after a designated time. We first propose to use in vivo two-photon imaging through cranial
windows to track and visualize the generation, loss, and replacement dynamics of OLs and myelin in this model,
determining the timeline of events occurring after ablation is induced and whether OLs demonstrate cellular age-
related resistance to ablation. Data acquired in this aim will provide interesting insight into the cellular and
subcellular changes adult-born OLs undergo in response to ablation. To elucidate the functional contribution of
activity-generated OLs on neuronal circuitry, we will use a contextual fear conditioning paradigm to induce
oligodendrogenesis. Rather than blocking the generation of new OLs after learning, a common model in the field,
we will permit OLs to generate and integrate onto neuronal circuitry before ablation and use post-ablation
freezing behavior to determine whether the sustained integration of OLs is required for fear memory. The data
and knowledge gathered from successful completion of these aims will provide valuable insight into the cellular
and circuit dynamics of adult-born OLs.

Public health relevance
PROJECT NARRATIVE During this fellowship, I am exploring the biology of adult-born oligodendrocytes (OLs), a large population of non- neuronal cells in the central nervous system responsible for insulating axons in myelin and shuttling critical resources to the underlying neuron. I am using a combination of in vivo imaging and behavioral paradigms, leveraging a novel mouse line I recently generated in the lab, to provide critical insight into the generation and loss dynamics of adult-born OLs and their potential roles in homeostatic regulation of memory circuitry. This work will further our understanding of OL death dynamics and the functional implications of such loss, generating foundational knowledge with potential implications for understanding and treating demyelinating diseases.